METALLOTHIONEIN IN NICKEL CARCINOGENESIS

The properties of Ni(II) bound to zinc finger peptides of transcription factors have been investigated by EPR to determine if redox reactions of these metallopeptides generate hydroxyl or superoxo radicals.